Actionable categories of avoidable hospital care among adults with cancer

PROJECT SUMMARY/ABSTRACT
Nearly all provider groups in Medicare’s five-year Oncology Care Model alternative payment program
expressed a goal to reduce hospital use by cancer patients, but very few achieved this. Identifying potentially
avoidable hospital care for cancer patients using diagnosis codes is difficult: depending on the definition used,
20-60% of hospital visits may be avoidable. The leading diagnosis code-based definition is the chemotherapy
outpatient quality measure (OP-35), which collects emergency department (ED) and inpatient admissions with
~300 discharge diagnosis codes into 10 avoidable conditions. Unlike similar measures of avoidable hospital
care for general patients, OP-35 has not yet been clinically validated. While OP-35 allows payers to compare
groups of providers, two issues limit its usefulness to cancer providers: First, clinicians might agree that some
OP-35 conditions (e.g. nausea/vomiting) are treatable in an outpatient or urgent care setting, but that others,
such as hematemesis (bloody vomiting), would be difficult to evaluate outside of a hospital. Second, OP-35
reports only a percentage of hospital visits to each provider group, obscuring what exactly is driving avoidable
hospital use. Based on preliminary work, we propose to develop a classification of actionable scenarios leading
to hospital care (e.g. patient required non-emergent procedure; patient did not call for triage help beforehand)
so that cancer providers can better understand how to reduce this frequent, disruptive, and costly aspect of
treatment. We will assemble an integrated dataset from tumor registry, electronic medical record (EMR), and
regional health information exchange data, for a diverse sample representing a range of cancers across all
insurance types, including the uninsured. This dataset will identifiably link >75% of all hospital visits in a 100-
mile radius of Dallas, TX, to the EMR of three large health systems in the region. Our aims are: Aim 1:
Clinically validate diagnosis code-based measures of avoidable hospital care (including OP-35) with clinician
EMR review; re-categorize hospital visits into actionable scenarios; and specify a new measure for oncology
urgent care-treatable conditions. H1: Most OP-35 defined avoidable will not be avoidable based on clinician
review. H2: Actionable categories of clinical scenarios will be identifiable in the EMR, and can be further
specified by a measure that identifies conditions treatable in an urgent care setting. Aim 2: Prospectively
validate our actionable categories and new oncology urgent care-treatable conditions measure with patients
and ED clinicians using post-discharge interviews. H1: Patients and ED clinicians will largely agree with our
categorizations, with some refinements. Aim 3: Conduct a national survey of cancer provider groups to assess
the feasibility and applicability of our new definitions for avoidable hospital care, in the context of their acute
care management capabilities. H1: A broad range of cancer providers will find our definitions feasible and
useful. Findings from our study will advance quality measurement and data-driven care improvement, and will
be especially useful to participants in Medicare’s upcoming Enhancing Oncology Model payment program.

Public health relevance
PROJECT NARRATIVE We will examine existing quality measures that define avoidable hospital care among adults with cancer and compare their performance to in-depth clinician reviews of medical records. We will recategorize hospital visits into actionable clinical scenarios to help cancer providers identify avoidable hospital visits and create a new quality measure to identify conditions that could be treated in oncology urgent care clinics. We will validate findings with patients and emergency clinicians, then survey cancer care providers nationwide to ensure that these categories and quality measure are accurate and useful.